Enrichment Program

PROJECT SUMMARY – Enrichment Program
The Chicago Center for Diabetes Translation Research Enrichment Program (CCDTR EP) is designed to amplify
T2-T4 diabetes research focused on population health and health equity through the promotion of scientific
exchange among Chicago-area and national junior and senior investigators. Diabetes translation research
encompasses a broad array of research methods from behavioral research to clinical trials to community-based
participatory research to cost-effectiveness analysis, and the proposed enrichment program reflects the diversity
of these areas. The CCDTR EP is designed to integrate key elements of UC and NU diabetes translation
research infrastructure and complement this integration with outside resources to improve population health and
health equity for vulnerable populations with diabetes. With the integration of NU into the CCDTR, there is an
important opportunity to create a robust cross-Chicago program of diabetes translation seminars, guest
speakers, visiting scientists, consultants, and workshops. The Specific Aims of the CCDTR EP will be to: Aim
1) Enhance and enrich the environment for diabetes translation research in Chicagoland through seminars,
symposia and workshops for trainees, junior investigators, senior investigators, and non-academic stakeholders;
and Aim 2) Create a Chicagoland network of diabetes translational investigators who work together and with
City of Chicago public health leaders to improve diabetes health and diabetes health disparities. We will establish
a joint CCDTR incubator weekly meeting and cross-pollinate UC and Northwestern researchers by integrating
cross-institutional leaders in the planning of the CCDTR-sponsored Annual Chicago Diabetes Day and NU's
Institute for Public Health and Medicine's Annual Population Health Forum. In addition, the CCDTR EP will
intentionally connect with investigators from diverse backgrounds and community stakeholders throughout
Chicagoland to join the center in order to strengthen collaborations and provide opportunities for dissemination.
Finally, the CCDTR EP will systematically identify and connect with all of Chicagoland's diabetes translation
researchers, public health experts, and community stakeholders. The major benefit of the CCDTR EP will be to
provide diabetes researchers, ranging from trainees to senior investigators, as well as partners and stakeholders,
with a forum to collaborate, innovate, and disseminate outstanding diabetes translation research. In concert with
other CCDTR activities, the EP will accelerate the equitable conduct, dissemination, and implementation of
translational diabetes research across Chicagoland.